Planning and Updating in Frontoparietal Networks for Grasping

Abstract
The control of movement, in spite of its seemingly effortless execution, belies a complex, multi-level collective of
neuromuscular interactions tuned and coordinated through sensory experience. Efficient and flexible behavior
in everyday contexts requires neural mechanisms that support rapid updating whenever objects around us, or
even our own movements, are disrupted during ongoing motion. As a movement unfolds, the need for predictive
or responsive control to correct for contextual perturbations changes. For example, the early stages of an action
typically exhibit fast responses to perturbations, suggesting the existence of feed-forward processes that use
internal models to predict the sensory consequences. On the other hand, later phases appear to employ
continuous sensory feedback to adjust movements. While much is known about updating for postural and arm
movements, very little is understood about the neural mechanisms of updating of dexterous movements of the
hand as we interact with objects. While the reach-to-grasp cortical anatomy is well described, the causal
functional roles of the regions still remain elusive. In particular, it is now becoming clear that the dominant
framework which describes reach-to-grasp control as being under the control of independent frontoparietal
channels is untenable because it does not explain recent empirical neurophysiological findings. Therefore, the
current project aims to leverage non-invasive stimulation to induce transient cortical perturbations, paired with
visual perturbations to the task goal and mechanical perturbations of the internal state of the limb, to causally
evaluate the contributions of four critical brain regions in components of the reach-to-grasp action. The
information derived from this work will provide a more solid background for our understanding of the functional
organization of the frontoparietal reach-to-grasp network and, by extension, of hand-arm control coordination.
This project will advance our empirical understanding of how dexterous updating of the upper limb, in particular
reach-to-grasp actions, are orchestrated by the brain. The knowledge will be immediately applicable and
translatable for rehabilitation of upper limb recovery in stroke and other similar disorders, by using error
augmentation through visual and haptic platforms to facilitate skill reacquisition and identifying cortical targets
for non-invasive neuromodulatory stimulation. These findings will be relevant to the mission of the NIH, with
broad interest to clinicians and basic scientists, and will have direct

Public health relevance
Narrative This project will advance our empirical understanding of how dexterous updating of the upper limb, in particular reach-to-grasp actions, are orchestrated by the brain. The knowledge will be immediately applicable and translatable for rehabilitation of upper limb recovery in stroke and other similar disorders, by using error augmentation through visual and haptic platforms to facilitate skill reacquisition and identifying cortical targets for non-invasive neuromodulatory stimulation. These findings will be relevant to the mission of the NIH, with broad interest to clinicians and basic scientists, and will have direct public health relevance.